Developmental Funds: New Shared Resources

Developmental funds have played an important role in the development of the Cancer Center, particularly in recruiting new investigators and in establishing new shared resources. During the current funding period developmental funds were instrumental in the recruitment of six new investigators and in the development of two new shared resources (Bioinformatics and Proteomics). We propose to continue our recruitment efforts to strengthen the scientific programs of the Cancer Center, and to develop a new shared resource devoted to Chemical and Systems Biology.